CRCNS: Linking Synaptic Populations and Computation Using Statistical Mechanics

Computations performed by single neurons result from integration of a large myriad of synaptic inputs
distributed throughout complex dendritic topology. Synaptic inputs vary in substantial ways; sensory-driven
activity patterns, probability of activation, synapse location within the dendritic topology, local dendritic
organization, and ultrastructural characteristics are all thought to be critical for determining how synaptic
inputs influence the spiking output of a neuron. Populations of synaptic inputs, ultimately, determine the
coding capacity and computations single neurons can perform. Despite this fact, studies largely overlook the
synaptic input population within a single neuron, instead focusing on the activity of cellular populations, using
biophysical models or constructing models that create hypothetical weights or synapses (e.g. deep-neural
networks). Thus, a critical question in neuroscience remains how ensemble synaptic activity is integrated in
vivo and what are the fundamental principles of synaptic organization which describe neural computation.
To address this issue, we present a tightly integrated experiment-theory approach. We propose to (1)
measure the sensory-driven activity patterns of large populations of dendritic spines on layer 2/3 visual
cortical neurons in ferret visual cortex in vivo, and (2) use a statistical physics approach to characterize the
structure and computing of synaptic populations in multiple contexts. Thus, this project will provide
fundamental knowledge about the synaptic architecture of neurons in the brain. The

Public health relevance
Synaptic organization is critical for understanding the normal function of neurons and for understanding how neurological disorders and stroke alter that function. This project makes relevant and fundamental contributions to the mission of NINDS by provide a new framework for studying synaptic organization that can be used to better understand normal neuronal function and changes in function due to neurological disorders.